CVM Vet-LRN Veterinary Diagnostic Laboratory Program MD Dept of Agriculture- Frederick Animal Health Lab

Abstract: The focus of this proposal is to seek funding for the Frederick Animal Health Laboratory (FAHL) to support
the mission of Vet-LIRN (Veterinary Laboratory Investigation and Response Network), though animal diagnostic
necropsy services, sample analysis, surveillance and animal food/drug emergency outbreak testing. FAHL is an ISO
17025 Accredited diagnostic laboratory and is part of the Maryland Department of Agriculture. FAHL has the staff,
equipment, technology, and management system to be able to provide critical resources that will benefit and support
Vet-LIRN.

Public health relevance
Project Narrative: Recent years have seen an increase in the threats to the food safety and security of both human and animal food supplies. In the proposed cooperative agreement Frederick Animal Health Laboratory will partner with the Veterinary Laboratory Investigation and Response Network (Vet- LIRN) to provide increased resources for the investigation of and response to animal food related illnesses.